The Upstream Center: Income Interventions to Address the Fundamental Causes of Cancer Inequities

Overall Component: Project Summary/Abstract
Persistent poverty environments impose particular challenges for cancer prevention, with complex and
intersecting factors creating barriers at the individual, health system, and population level. Improving cancer
outcomes in these areas requires transformational, multisector solutions targeting fundamental causes and
social determinants of health, with research and policy development processes that are co-created with the
impacted communities. To address this challenge, we will form the UPSTREAM Research Center, an
innovative approach to the fundamental problem of income deprivation by leveraging state programs for
Guaranteed Basic Income and the Earned Income Tax Credit (EITC). Our team science approach to this
problem is supported by the unparalleled resources at Stanford University, the University of California, San
Francisco and the University of California, Davis. Our work advances multiple conceptual and methodological
innovations through two main research projects: 1) an ongoing partnership with the California Department of
Social Services to access and evaluate a $35M intervention of Guaranteed Basic Income in persistent poverty
areas with a focus on modifiable cancer risk factors and intermediate outcomes; 2) the impact of increases in
income support through the EITC, which in California has a unique focus on lower income wage earners, as
well as undocumented workers. Our Specific Aims are to: Aim 1. Build a collaborative community of residents
in persistent poverty areas, policy makers, trainees, cancer and social science researchers and data scientists
that co-create programs to address the fundamental impacts of income deprivation, Aim 2. Evaluate the
impact of income-based interventions in demographically diverse persistent poverty areas in Northern CA, Aim
3. Develop a mathematical model, with community input, that can assist in predicting long-term impacts of
income-focused interventions on cancer incidence, providing community members, policy makers, and
researchers with guidance on how best to eliminate the increased burden of cancer in persistent poverty areas,
Aim 4. Develop and implement a career enhancement program that will facilitate the training and career
development of a diverse cadre of interdisciplinary early-career scholars who are committed to advancing
cancer health equity through research and practice in persistent poverty areas, and Aim 5. Implement
innovative and collaborative cancer prevention and control programs identified through the UPSTREAM
Research Center research projects and our community partners to develop long-term sustainable strategies in
our Northern CA Catchment Areas and across the Persistent Poverty Centers Network. Results from this novel
groundbreaking work will lay the foundation for transformative approaches to address cancer prevention and
control programs in the face of severe economic and social disadvantage through capacity building and
sustainable partnerships with policymakers, state and local agencies and community partners.

Public health relevance
Overall Component: Project Narrative Addressing a problem as daunting as persistent poverty and cancer requires approaches with a focus on changing the hazardous conditions in which people live, learn, work and play. The UPSTREAM Research Center, working with policy makers and community partners, will advance the science and practice of anti- poverty policies to prevent cancer in persistent poverty communities. Results from this work will lay the foundation for transformative approaches to address cancer prevention and control programs in the face of severe economic and social disadvantage through capacity building and sustainable partnerships with policymakers, state and local agencies and community partners.